Ultrabright Plasmonic-Fluor Nanosensor-Enabled Noninvasive Management of Pediatric Nephrotic Syndrome

Abstract
Pediatric nephrotic syndrome (NS), characterized by proteinuria, hypoalbuminemia and progressive loss of
kidney function, is a debilitating childhood kidney disease. In addition, steroid-resistant NS, accounting for about
10% of end-stage kidney disease in the pediatric population, may require long-term use of immunosuppressants
that can cause nephrotoxicity. The daunting difficulty in pediatric venipuncture, as well as the small volume limit
of maximum blood draw allowed for a single draw and within 2 months, especially in neonates, infants and young
children, has limited close monitoring of serum albumin and kidney function in the active phase of NS. Moreover,
urine dipstick test, as a semi-quantitative and not-always-reliable assay, is a crude way of evaluating the
treatment response. It is also unable to assess the serum albumin level and kidney function that may be
compromised by volume contraction, routine use of diuretics and angiotensin-converting enzyme inhibitors, and
drug-induced renal toxicity acutely. Thus, development of an innovative, pain-free and volume extraction-free,
and highly sensitive biodiagnostic platform is imperative to improve the clinical care for pediatric NS patients.
Bioanalyte-rich dermal interstitial fluid (ISF) provides a novel opportunity to achieve painless and effective
biodiagnostic technologies. However, the clinical utility of ISF is limited by the current technology. Our goal is
to develop our newly invented ultrabright plasmonic-fluor (PF)-enabled microneedle (MN) technology
(PF-MN) as an ultrasensitive and minimally-invasive diagnostic tool for rapid sampling and quantification
of ISF albumin, blood urea nitrogen (BUN) and creatinine (Cr) in point-of-care settings and at home. To
accomplish our research goals, we will utilize a highly reproducible hereditary NS mouse model. In this preclinical
model, we aim to demonstrate minimally-invasive detection of albumin in the mouse dermal ISF by employing
PF-enhanced fluoroimmunoassay (p-FLISA) on a MN patch. We will also determine concentrations of BUN and
Cr in the dermal ISF by using PF-enhanced competitive immunoassay performed on MN. Furthermore, we will
correlate their concentrations derived from MN-sampled ISF, extracted ISF and serum.
A successful completion of our pioneering proposal may lead to a paradigm-shift in the newborn and pediatric
diagnostics. It will also pave the way for future translational study in pediatric NS patients.

Public health relevance
The proposed research is relevant to public health because it aims to develop a microneedle-based, blood draw-free diagnostic platform that can be implemented in point-of-care settings and at home. Specifically, in this project we will investigate whether the plasmonic-fluor-enabled microneedle-based highly sensitive biodiagnostic technology can be utilized for minimally-invasive and frequent monitoring of kidney function in the nephrotic syndrome mouse model, which may transform the current management of pediatric nephrotic syndrome patients.